Function of Wdfy4 in cross-presentation and immunity

Project Summary
This application will investigate the molecular and cellular mechanisms underlying antigen cross-presentation
by dendritic cells (DCs), with a major focus on type 1 classical DCs (cDC1) which play a major role in priming
CD8 T cell responses that are critical for cancer immunotherapy. Cross-presentation involves the presentation
of exogenous antigens by MHC-I molecules, which is predominantly facilitated by cDC1 in vivo. This
application will address critical gaps in understanding the cross-presentation process and its implications for
immune responses, leveraging several novel in vivo models that we have produced to elucidate the specific
roles and mechanisms of cDC1 and cDC2 in antigen processing and presentation. A central facet of our
proposal is the investigation of WDFY4, which we identified as critically important for cross-presentation by
cDC1. Our preliminary data reveal a pivotal role in mediating CD8 T cell responses against viruses and tumors,
and implicating it in autoimmunity contexts such as type I diabetes. The proposal aims to define the molecular
basis of cross-presentation, challenging alternative models by providing rigorous data supporting vacuolar
pathways for antigen processing that involve WDFY4. Specifically, our proposal challenges the models that
rely on a cytosolic route, by providing both an explanation for the apparent dependence on the TAP transporter
and evidence for TAP-independent cross-presentation. Aims of this proposal are twofold: firstly, we will
rigorously test the hypothesis that WDFY4-dependent cross-presentation in cDC1 employs a vacuolar
pathway, contrasting it with the cytosolic route and assessing the role of the TAP transporter in this process.
Secondly, we will define the molecular interactions of WDFY4 with proteins that mediate its actions and
determine whether they are involved in regulating vesicular trafficking, cargo sorting, or cytoskeletal dynamics,
which are crucial for the cross-presentation of antigens. This will involve identifying and validating interacting
proteins, determining their structural relationships with WDFY4, and elucidating their functional relevance to
cross-presentation in vitro and in vivo. By challenging existing paradigms and employing cutting-edge genetic
and molecular tools, this research promises to significantly advance our understanding of dendritic cell biology,
particularly the cellular and molecular mechanisms of antigen processing and presentation. The outcomes are
expected to enhance our understanding of immune activation and to have broad implications for the design of
more effective cancer immunotherapies and interventions for autoimmune diseases.

Public health relevance
Project Narrative Our application focuses on the complex mechanisms of cDC1 cross-presentation, a key process in effective immune responses to viruses and tumors, and for checkpoint blockade immunotherapy. We aim to dissect the cellular and molecular basis for this process, particularly emphasizing the role of WDFY4. This research has the potential to illuminate new pathways for cancer immunotherapy, enhancing our understanding of how the immune system targets tumors.